A Culture Centered Narrative Approach for Health Promotion

DESCRIPTION (provided by applicant): Latina adolescents experience high rates of birth, HIV infection, and other sexually transmitted infections (STIs), both nationwide and in Holyoke.1 Latinas have the highest teen birth rate of any major ethnic/racial minority in the U.S. at 70.1/1000 births, in comparison to an overall teen birth rate of 39.1/1000.2 Among all racial/ethnic groups, Latinos rank second for all adult and adolescent HIV diagnoses.3 In 2009, U.S. Latinas ages 15-19 had rates of Chlamydia at 21.9/1000, in comparison to 11.37/1000 for their white peers.4 Behavioral interventions that seek to promote safer sex among Latino/a youth often fail to address the cultural values that can drive individual's decisions and actions. As a result, they are often ineffective.5 There is a clear imperative to identify, disseminate, and implement culturally specific narrative-based interventions. Interventions that engage youth participants in arts- and narrative-based processes, 6-8 while also acknowledging their everyday realities and the variability in meanings of sexuality, including a positive sexuality perspective, 9, and 10 may be effective for promoting sexual health and wellbeing. By foregrounding the voices of young Latinas to articulate their own meanings of health, and considering these perspectives in the development of health promotion programs,11 culture-centered approaches can effectively promote positive sexual health outcomes.12,13 While culturally centered content has been linked to sexual health promotion among young Latinas, with culture-centric health promotion messages evaluated for their overall effectiveness,13,19,20 the narrative process itself has not been well tested for the way that it works as a mechanism of health promotion. Our multidisciplinary project team proposes to use a young person-driven, researcher-facilitated narrative methodology21 to address this research gap. The proposed project takes a narrative approach, using digital storytelling (DST) to rigorously map the mechanisms by which participants form culturally specific meanings of sexuality, sexual health, and wellbeing. Resulting culturally specific data will be used to inform the future development of culturally centered sexual health interventions. The impact of the process will result in increased levels in self-esteem and clarity of personal sexual values, increases in sexual decision-making and communication skills, and an increase in perceived choices in one's actions among participants. The specific aims of this project are to (1) Identify cultural paradigms of sexual health among three groups of adolescent Puerto Rican Latinas; (2) Assess the effects of the process of creating digital stories on participants' sexual attitudes/values, self-determination, and use of protective behaviors; and (3) Explore the perceived value of produced digital stories for workshop participants, to inform the choice of resonant digital stories for use in a larger scale promotion effort in the next phase of research.

Public health relevance
PUBLIC HEALTH RELEVANCE: Latina adolescents experience high rates of birth, HIV infection, and other sexually transmitted infections (STIs), both nationwide and in Holyoke, the proposed site for this exploratory project. We propose to use a narrative approach, digital storytelling, that will result in culturally specific data to be used in the future development of culturally centered sexual health interventions, and increased levels in self-esteem and clarity of personal sexual values, increases in sexual decision-making and communication skills, and an increase in perceived choices in one's actions among participants. The core elements of the intervention (i.e., the digital storytelling process) will be generalizable to other cultural group, while other important features (i.e., the digital stories themselves) will be adaptable, thereby increasing the utilization of findings. __SpecificAimsTextDelimiter__ 1. Specific Aims The proposed project employs a culture-centered approach to promote healthy and safer sexual behaviors among adolescent Puerto Rican Latinas living in Holyoke, MA, the site of the proposed project. Latina adolescents experience high rates of birth, HIV infection, and other sexually transmitted infections (STIs), both nationwide and in Holyoke.1 Latinas have the highest teen birth rate of any major ethnic/racial minority in the U.S. at 70.1/1000 births, in comparison to an overall teen birth rate of 39.1/1000.2 Among all racial/ethnic groups, Latinos rank second for all adult and adolescent HIV diagnoses.3 In 2009, U.S. Latinas ages 15-19 had rates of Chlamydia at 21.9/1000, in comparison to 11.37/1000 for their white peers.4 Behavioral interventions that seek to promote safer sex among Latino/a youth often fail to address the cultural values that can drive individual's decisions and actions. As a result, they are often ineffective.5 Innovative approaches to sexual health promotion are needed. Interventions that engage youth participants in arts- and narrative-based processes,6-8 while also acknowledging their everyday realities and the variability in meanings of sexuality, including a positive sexuality perspective,9,10 may be effective for promoting sexual health and wellbeing. By foregrounding the voices of young Latinas to articulate their own meanings of health, and considering these perspectives in the development of health promotion programs,11 culture-centered approaches can effectively promote positive sexual health outcomes.12,13 In a culture-centered approach, culture is defined as the local or specific contexts within which shared systems of meaning are constituted and negotiated.11 Culture-centered approaches consider the fluidity of contexts (i.e., socio-political histories of migration and acculturation, gender expectations, socioeconomic status, and access to resources) that cut across meanings of health. From this perspective, meanings of sexual health are holistically embedded in specific cultural contexts and the associated value systems of everyday life.11,14,15 Researchers have documented the effectiveness of culture-centric narrative health promotion for achieving positive behavior change.16-18 While culturally centered content has been linked to the promotion of positive sexual health outcomes among young Latinas, with culture-centric health promotion messages evaluated for their overall effectiveness,13,19,20 the narrative process itself has not been well tested for the way that it works as a mechanism of health promotion. Our multidisciplinary project team proposes to use a "young person-driven, researcher-facilitated" narrative methodology21 to address this research gap. Our strategy is to use digital storytelling (DST) as a narrative process for analyzing the ways in which participants specify their own, culturally-grounded understandings of positive and healthy sexual values and practices (cultural paradigms of sexual health), and then measure the effect of this narrative process on participant sexual attitudes, values, and behaviors. As a new media form of storytelling, DST engages participants in creating and sharing brief, visually appealing narrative accounts of life events. Digital stories are short, first person visual narratives that synthesize digital image, audio recording, music, and text to document personal experiences.22 We have previously conducted DST workshops with adolescent Puerto Rican Latinas in Holyoke to explore gendered growing-up experiences.23-25 Here, we will use DST to map narrative processes that relate to specific cultural values of healthy relationships and safer sexual behavior among workshop participants. A formative hypothesis guiding the proposed research is that the DST process surfaces culturally relevant narratives that can be used to (a) identify core cultural paradigms that shape sexual behaviors, and (b) positively influence the sexual attitudes, values, and behaviors of young Puerto Rican Latinas at high risk. Our specific aims are to: Aim 1: Identify cultural paradigms of sexual health among three groups of adolescent Puerto Rican Latinas. Aim 2: Assess the effects of the process of creating digital stories on participants' sexual attitudes/values, self-determination, and use of protective behaviors. Aim 3: Explore the perceived value of produced digital stories for workshop participants, to inform the choice of resonant digital stories for use in a larger scale promotion effort in the next phase of research. Provided that outcome evaluation and data analysis steps from this exploratory project yield promising data, we will design a full study to test the piloted approach as an intervention in a randomized controlled trial, comparing the use of a culture-centered narrative-based intervention approach to a standard intervention focused on sexual decision-making behavior change and reproductive health outcomes among disadvantaged young Latinas. Our long-term program of research focuses on developing a culture- centered narrative health promotion process aimed at reducing sexual health disparities in at-risk communities. While we see produced narratives as rooted in cultural specificity, the digital storytelling process is transferable as a culture-centered intervention approach for use with other at-risk populations and to address other public health issues.